Investigating the effect of mechanical compliance of metamaterial interbody cages on spinal fusion progress in vivo

PROJECT SUMMARY
There is an unmet need for understanding the complex relationships between the compliance of
interbody fusion cages, interbody loading, load-sharing, and the progression of spinal fusion in vivo.
Interbody fusion cages are spinal implants that have become highly popular over the last decade. An ideal
interbody fusion cage should be sufficiently stiff and strong to limit interbody motion and relieve the pressure that
may be causing pain, while “compliant” enough to allow sufficient load to be transferred through the spine to
maintain bone. We propose to investigate the effect of the mechanical compliance of interbody cages on
the spinal fusion rate and the subsidence of spinal segments in ovine models. To this aim, we will create
the first-of-their-kind compliant metamaterial fusion cages with tunable stiffness, porosity and energy
absorption, and will implant them in ambulatory vertebrate animals. We hypothesize that the proposed
metamaterial interbody cages with local compliance and reduced stiffness foster more consistent load-sharing
during the full range of motion from flexion to extension. This is clinically significant because load-sharing through
the interbody space stimulates bone formation and maturation and may ultimately lead to better outcomes.
Therefore, we hypothesize that the compliant metamaterial cages introduce a softer stabilization approach
leading to a faster bone formation and better fusion. Our first objective will be to perform topology optimization
to develop a series of “mechanically-optimized” metamaterial cages, which can be adapted to function in animal
models. We will create a computational framework that can serve as a universal method for the accelerated
design of the compliant fusion cages across a full relative density range with various biocompatible material
options. The fabricated cages will be mechanically tested following the protocols described by the ASTM
standards F2077 and F2267 to establish their static/dynamic fatigue properties, height loss and subsidence. Our
second objective will be to investigate the effect of metamaterial cage compliance on the rate of fusion using
sheep cervical spine models following anterior cervical discectomy and fusion (ACDF). We aim to deploy eight
adult sheep. The animals will be separated into “baseline control” and “compliant fusion” groups. The optimal
cage configuration with rationally designed unit cells and auxeticity will be used to design two cage types:
baseline stiff (100% stiff) and compliant types (20% stiff). Four animals will be instrumented with each of the
baseline 100% and 20% stiff cages. Digital imaging, microCT analysis and histological assessment will be
performed for evidence of fusion and cage subsidence. We expect that animals in the compliant group have
more extensive bone formation and superior rates of fusion compared with the animals in the baseline control
100% stiff group. The proposed experimental concept paves the way for the design of next-generation
compliant metamaterial fixation-devices for other treatments and therapeutics of fracture repair.

Public health relevance
PROJECT NARRATIVE We propose to investigate the complex relationships between the compliance of interbody metamaterial fusion cages, load-sharing, and the progression of spinal fusion in vivo. We hypothesize that the proposed metamaterial interbody cages with local compliance and reduced stiffness foster more consistent load-sharing and lead to a faster bone formation and better fusion. The proposed experimental concept paves the way for the design of next-generation compliant metamaterial orthopedic implants and fixation devices for therapeutics of fracture repair.